A Phase 1 Study to Evaluate Chimeric Antigen Receptor (CAR) T cells Targeting TAG72 in Patients with Recurrent Epithelial Ovarian Cancer

PROJECT SUMMARY
Patients with recurrent epithelial ovarian cancer (EOC) have a poor prognosis with a post-relapse median
survival of approximately 30 months and limited therapeutic options, thus presenting a fundamental unmet
medical need. Progress in immunotherapy across a broad range of tumor types provides hope that
immunological approaches may improve outcomes for patients with EOC. Particularly, a type of immunotherapy
called chimeric antigen receptor (CAR) T cell therapy retrains the immune system to target cancers by
recognizing specific cancer markers. EOC presents several challenges to effective CAR T cell immunotherapy,
including poor tumor site infiltration, activation, inadequate function and persistence of these T cells within the
harsh peritoneal tumor microenvironment. Additionally, there are a lack of effective CAR T cell targets on the
surface of advanced EOC tumor cells. Our goal is to develop effective therapies against metastatic EOC, with a
specific focus on regional delivery of CAR T cell therapies to treat peritoneal metastasis. TAG72 is highly over-
expressed in EOC and other solid tumors with little or no expression in normal tissues, making it an ideal target
for CAR T cell therapy. Our team at City of Hope has developed and completed laboratory testing of a TAG72-
targeting CAR T cell therapy. Our preclinical data also supports superior anti-tumor activity when TAG72 CAR T
cells are administered regionally by intraperitoneal delivery versus systemically by intravenous delivery, likely
due to direct and immediate antigen CAR T cell access to tumor cells. The hypothesis is that regionally-
administered TAG72-CAR T cells will be safe and mediate anti-tumor effects, which will be assessed in the
following specific aims: 1) Evaluate safety and feasibility of regional intraperitoneal delivery of TAG72-CAR T
cells in patients with advanced EOC in a phase 1 clinical trial; 2) Assess CAR T cell-mediated immune landscape
changes that may indicate therapeutic response or resistance; and 3) investigate pathways of tumor resistance
and CAR T cell-induced tumor evolution. Our program has incorporated an innovative use of pre-conditioning
regimens to our solid tumor CAR T cell therapies, regional routes of CAR T cell administration, and a fully-
optimized TAG72-CAR construct. These features aim to improve the potency and selectivity of targeting TAG72+
tumors while potentially minimizing immune responses that limit persistence and/or function of TAG72-CAR T
cells. This approach is significant in that it will expand our therapeutic portfolio for EOC and other solid tumors.

Public health relevance
NARRATIVE Patients with advanced epithelial ovarian cancer (EOC) become resistant to platinum-based chemotherapies after which they have few treatment options and very short lifespan. The proposal clinically evaluates a newly developed chimeric antigen receptor (CAR) T cell therapy against EOC by redirecting the patients’ own immune T cells against the tumor target TAG72, which is highly expressed on the tumor cells. We have designed this potent immunotherapy to improve outcomes for patients with advanced EOC.